Administrative Core

In response to a Funding Opportunity Announcement for multi-institutional teams to form a Glioblastoma Therapeutics Network (GTN) basic scientists and clinical/translational investigators from three institutions in the Dana-Farber/Harvard Cancer Center have joined forces with their counterparts in the Stanford Cancer Center to create the “Harvard/Stanford GTN”. The GTN study plan features three Projects an Administrative Core, a Pharmacological and Genomic Imaging Core and a proposed Network Coordinating Center (NCC). The Administrative Core will be based at Brigham and Women’s Hospital, the parent organization for the Harvard/Stanford GTN, and will serve as the coordinating center and hub for the four institutions comprising the program and all interactions with existing P30-supported resources for clinical trials. The core will coordinate internal and external components of this complex structure to foster and support multi-project, inter-disciplinary, and inter-institutional drug development research in adult glioblastoma. Core personnel include one GTN Principal Investigator, three Site Leads at the Harvard/Stanford GTN institutions, two scientific co-administrators, a program coordinator, two grants specialists, and an administrative assistant. There are four Specific Aims in the Administrative Core. In the First Aim, the core will develop and engage a multidisciplinary Internal Advisory Board to provide critical oversight of the overall Harvard/Stanford GTN program. In the Second Aim, the core will organize regular meetings of key stakeholders to foster collaboration, troubleshooting, and monitoring of progress. In the Third and Fourth Aims, the core will maintain a trans-institutional program for regular, internal and external electronic communication among Harvard/Stanford project and core co-leads, clinical trialists, the GTN Steering Committee, the NCC, NCI program officials, and industry partners. The Administrative Core Leader, Tracy Batchelor, M.D., will serve as the overall Principal Investigator of the Harvard/Stanford GTN program with able assistance from Site Leads at Dana-Farber Cancer Institute (Patrick Wen, M.D.), Massachusetts General Hospital (Isabel Arrillaga, M.D., Ph.D.), and Stanford University (Michelle Monje, M.D., Ph.D.). This trans-institutional administrative team at Dana-Farber/Harvard Cancer Center and Stanford Cancer Center have worked together effectively on other multi-center, multi-project, NCI-sponsored glioma research projects.